Medications for Obstructive Sleep Apnea to Improve Cognition in Children with Down Syndrome (MOSAIC DS)

Children with Down syndrome (DS) are known to be at very high risk for obstructive sleep apnea (OSA), with a
prevalence of up to 66%. OSA has been associated with neurocognitive impairment and impaired health-
related quality of life (HR-QOL) in children with DS. Current treatments for OSA in children with DS include
adenotonsillectomy and positive airway pressure (PAP) therapy. Unfortunately, treatment effectiveness is
limited by a high risk of residual OSA after adenotonsillectomy and poor adherence to PAP therapy. OSA is
prevalent among children with DS and is associated with neurocognitive impairment and impaired HR-QOL.
Targeted therapies are needed to mitigate these negative effects of OSA in children with DS. Airway hypotonia
during sleep has been identified as a cause of OSA in children with DS. Consistent with this, OSA treatment
aimed at improving airway tone via hypoglossal nerve stimulation appears to be effective in adolescents with
DS. However, use of hypoglossal nerve stimulation may be limited in children given that multiple revision
surgeries would likely be necessary in younger children to adjust for growth over time. The combination of
atomoxetine and oxybutynin (ato-oxy) was shown to improve airway tone during sleep and treat OSA in adults
without DS. Given that both drugs are routinely used and well-tolerated in children, we hypothesize that ato-
oxy will be an efficacious treatment for OSA in children with DS and will lead to improvement in neurocognition
and HR-QOL. Specific aims of this project during the R61 phase include: Aim 1: To evaluate the short-
term efficacy of ato-oxy treatment for OSA in children with DS. Aim 2: To evaluate the short-term efficacy of
ato-oxy treatment on improving HR-QOL in children with DS and OSA. Specific aims of this project during
the R33 phase include: Aim 3: To evaluate the long-term efficacy of ato-oxy treatment for OSA in children
with DS. Aim 4: To evaluate the long-term efficacy of ato-oxy treatment on improving HR-QOL in children with
DS and OSA. Aim 5: To evaluate the efficacy of ato-oxy treatment on improving neurocognition in children with
DS and OSA. If successful, this project would identify a novel treatment for OSA in children with DS, as well as
medication-based route to improve cognition in children with DS.

Public health relevance
Project Narrative Obstructive sleep apnea is common in children with Down syndrome and current treatments such as adenotonsillectomy and positive airway pressure therapy have limited effectiveness in children with Down syndrome. This project will evaluate the combination of two medications, atomoxetine and oxybutynin, as a treatment for obstructive sleep apnea in children with Down syndrome. Effective obstructive sleep apnea therapy with these medications may lead to improved quality of life and cognition in children with Down syndrome.